University of Iowa Institute for Clinical and Translational Science

ABSTRACT
The Institute for Clinical and Translational Science (ICTS) at the University of Iowa (UI) has three aims – (1) to
promote an innovative, integrated, geographically distributed framework for conducting clinical and
translational research, 2) to create new methods and tools that promote research participation, data collection,
and interventions that link the clinic to the home and 3) to develop the diverse workforce needed to catalyze
innovative science throughout populations. ICTS tackles large problems affecting translational science that
require institutional solutions, such as transforming regulatory processes for human subjects research,
developing an informatics infrastructure for integrating electronic medical record and other health care data,
establishing bi-directional relationships with community organizations, and revitalizing the pipeline of well-
trained clinical and translational researchers. Our overarching goal is to accelerate integration of research into
clinical partnerships around the state and, through team science, bringing our basic, translational and clinical
research workforce together to escalate the pace and breadth of scientific discovery to impact healthcare for
the state and beyond.
Iowa is a rural state, which brings special health care needs and challenges. We have used these rural
considerations as a catalyst for driving our approach to clinical and translational research pushing our teams to
develop strategies to engage rural populations of all ages and backgrounds and to create new approaches that
overcome the geographic barriers in a rural state. We are capitalizing on our established community practice
networks of family physicians, clinics, school nurses and pharmacists. We utilize mobile platforms in novel
ways and will test the efficacy of these methods of engagement. As we move research to “IMpact Across
Geographies using Innovation, Networks and Engagement- IMAG-INE” we have created methods to
capture real-time, real-life data from the home and to correlate this environmentally specific, comprehensive
data to human health research and outcomes. The ICTS is engaging with other CTSA hubs and national
clinical and translational research systems to empirically test different approaches and to develop the evidence
base of proven strategies for accelerating translation that can be more broadly disseminated. Though distance
and rurality drive our approaches, the strategies that we develop are simply new and potentially better ways to
generate broad representation and improved participation by patients, healthcare teams and academicians.
Through our local, state and national collaborations, UI and the ICTS are poised to move clinical and
translational discovery rapidly into healthcare practice in a variety of clinical settings.

Public health relevance
Project Narrative The mission of the University of Iowa Institute for Clinical and Translational Science (ICTS) is to accelerate the translation of scientific discovery into practical health care through programs that develop the translational science workforce, promote the engagement of community members, allied health providers and diverse populations that suffer from health disparities, and to catalyze innovations that enable transformations in the infrastructure and processes that support translational science. These efforts will lead to the development of novel therapies and healthcare delivery strategies, the integration of translational research into clinical practices, and, ultimately, to measurable improvements in the health of Iowa and the nation.